Multilevel Panel Study of Effects of Changes in Nursing on Health Equity and Patient Outcomes

The organizational context in which nursing care is delivered plays a key role in health outcomes for patients.
Through our NINR-sponsored program of research, continually funded since inception, we have produced vital
information from large and representative samples of organizations (e.g., hospitals, nursing homes, primary
care practices) on the impact of the context of nursing care on patient outcomes, health disparities, and nurse
well-being. The modifiable features of interest include ensuring sufficient nurse staffing and resources,
investing in nurse education, trusting nurses' autonomy to make informed clinical decisions and act, fostering
interprofessional teamwork and respect, and involving frontline nurses in policy and decision-making. We
conducted large-scale surveys of nurses in 1999, 2006, 2016, 2020, and 2021, aggregating their responses to
produce organization-level nursing measures, as well as indicators of nurse outcomes (e.g., burnout) that we
link with clinical outcomes data from patients in the same organizations. The majority of the work was cross-
sectional, and while suggestive, falls short of providing the confidence needed to translate evidence into major
policy and practice reforms. Our last renewal application enlarged the measurement and analytic frame to
longitudinal analyses of organizational changes and outcomes at two points in time in 4 states. In this renewal,
we will significantly extend and expand this work to enable replication of our data collection effort twice within
the study period in 7 states (CA, FL, IL, NJ, NM, NY, PA), creating a unique panel dataset of organizations, the
nurses working there, and the patients they care for, going as far back as 1999. We leverage a new
partnership to substantially reduce the cost of data collection and add states that allow for new questions about
the differential impact of nursing changes for various populations. The design emphasizes evaluation of factors
inducing change in nursing practice, distinguishing the impact of the active and intentional, e.g., Magnet
recognition, policies like staffing ratios, from the environmental and historical, e.g., COVID-19 pandemic,
hospital consolidation trends, on outcomes for patients of all ages, risk factors, and demographics. Our aims
are: 1) to determine whether there are sustainable effects of organizational change on nursing practice and
associated patient outcomes and cost across a range of patient populations and settings; 2) to determine
whether organizational nursing changes over time diminish health disparities and if the changes and their
effects differ in minority-serving and/or safety-net organizations; and 3) to examine if nursing-related policy
interventions (e.g., nurse-to-patient ratios [CA], staffing committees [NY]) and organizational innovations (e.g.,
Magnet/Pathway) aimed at improving outcomes through work environment reform had a sustained impact over
time and in the face of challenges like COVID-19. The overarching aim is to not just understand the benefits of
organizational change for patient outcomes, but to understand how to target organizational change via
intervention that can have a transformative impact on health equity, nurse wellbeing, and patient outcomes.

Public health relevance
Project Narrative By studying healthcare organizations, the nurses providing care in them, and the patients experiencing that care over time, we aim to understand the causal nature of effects that investments in nursing have on patient outcomes and health disparities. In doing so, we gain crucial information regarding where organizational reform is needed, and how best to design and target policy interventions and organizational innovations that can transform the care environment to maximize safe, effective, and equitable care for patients.